Innate and adaptive immunity in celiac disease

DESCRIPTION (provided by applicant): Celiac disease is a complex intestinal inflammatory disorder with villous atrophy induced by dietary gluten in HLA-DQ2 or HLA-DQ8 individuals. The disease is the 'tip of an iceberg' including a larger subclinical population with various aspects of dysregulation in response to gluten. Immunological abnormalities associated with gluten uptake include (1) chronic upregulation of IL-15 in the epithelium and lamina propria, (2) massive expansion of natural killer-like intraepithelial cytotoxic lymphocytes (IE-CTL), (3) DQ2 or DQ8-restricted anti- gluten CD4 T cells secreting IFNgγ in the lamina propria and (4) signature antibodies against gluten and the tissue transglutaminase (TTG) that binds and deamidates gluten. Villous atrophy may depend on the anti- gluten IFNgγ+ CD4 T cell response, the expansion of IE-CTL and the overexpression of IL-15, but the precise links between these effector mechanisms remain unclear. The overarching aim of this proposal will be to model and investigate in vivo the consequences of chronic IL-15 expression using established transgenic systems expressing IL-15 at levels comparable to those observed in disease, and dissecting expression in the intestinal epithelium (villin promoter, V-IL15tg) and outside the epithelium in the lamina propria DC (minimal MHC class I Dd promoter, Dd-IL15tg). The conclusions will then be tested against a cohort of relatives of celiac patients where these immunological abnormalities naturally segregate. The ultimate goal is to combine DQ8 and IL-15 to model the histopathological stages of celiac disease. Specific aim 1, will analyze the impact of IL-15 on the breakdown of oral tolerance to ingested gluten; Specific Aim 2 will analyze the role of IL-15 in the acquisition of a natural killer phenotype by intraepithelial lymphocytes and the development of villous atrophy; and Specific Aim 3, will analyze in human studies the link between IL-15, anti-gluten adaptive immunity and natural killer transformation of intraepithelial lymphocytes. Collectively, these studies will not only provide new insights into the pathogenesis of celiac disease and the major impact of dysregulated IL-15 expression but also, importantly, will guide and refine new generation animal models. Because a strict lifelong gluten-free diet imposes tremendous constraints on patients, such models are long overdue to test alternative therapies that will be developed in the near future.

Public health relevance
PUBLIC HEALTH RELEVANCE: Celiac Disease is an intestinal inflammatory intestinal disorder with a high prevalence (>1%), that is induced by dietary gluten. Understanding how different components of the immune system contribute to disease and developing a mouse model of celiac disease will have a major impact on our understanding of the disease, and the treatment and follow-up of celiac disease patients. PROJECT NARRATIVE Celiac Disease is an intestinal inflammatory intestinal disorder with a high prevalence (>1%), that is induced by dietary gluten. Understanding how different components of the immune system contribute to disease and developing a mouse model of celiac disease will have a major impact on our understanding of the disease, and the treatment and follow-up of celiac disease patients. __SpecificAimsTextDelimiter__ Specific Aims Celiac disease is a complex intestinal inflammatory disorder with villous atrophy induced by dietary gluten in HLA-DQ2 or HLA-DQ8 individuals (1-4). The clinical manifestation of disease is the 'tip of an iceberg' including a much larger undiagnosed population with various aspects of dysregulation of adaptive and innate immunity in response to gluten (5). Immunological abnormalities associated with gluten uptake include (i) chronic upregulation of IL-15 in the epithelium and lamina propria (6-8) (ii) massive expansion of natural killer-like intraepithelial cytotoxic lymphocytes (IE-CTL) (7, 9-11), (iii) DQ2 or DQ8-restricted anti-gluten CD4 T cells secreting IFNγ in the lamina propria (12-15), and (iv) signature antibodies against gluten and the tissue transglutaminase 2 (TTG) that binds and deamidates gluten (13, 16, 17). Villous atrophy may depend on the anti-gluten IFNγ+ CD4 T cell response, the expansion of IE- CTL and the overexpression of IL-15, but the precise links between these effector mechanisms remain unclear. Intensive but so far unsuccessful efforts have been deployed to create relevant animal models of celiac disease in order to probe the complex innate and adaptive immune mechanisms leading to villous atrophy and to test novel therapies. We have recently succeeded in modeling the CD4 T cell response to native and deamidated gluten peptides in humanized DQ8 mice (18) but, as expected, these mice did not overexpress IL-15 nor develop celiac disease. Based on published experiments and preliminary data, we hypothesize that IL-15 abrogates oral tolerance to gluten and at the same time induces the NK-like transformation of IE-CTL (9, 11, 19), both of which are required for disease induction. The overarching aim of this proposal will be to model and investigate in vivo the consequences of chronic IL-15 expression using established transgenic systems expressing IL-15 at levels comparable to those observed in disease, and dissecting the consequences of dysregulated IL-15 signaling in the intestinal epithelium (villin promoter, V-IL15tg), and outside the epithelium in intestinal DC (minimal MHC class I Dd promoter, Dd-IL15tg). The conclusions will then be tested against a cohort of relatives of celiac patients where these immunological abnormalities naturally segregate. The ultimate goal is to combine DQ8 and IL-15 to model the histopathological stages of celiac disease. Specific Aim 1: IL-15 induces a breakdown of oral tolerance to ingested gluten Preliminary data indicate that IL-15 expression in DC (but not epithelium) abrogates oral tolerance to the model antigen OVA. This aim will test the hypothesis that IL-15 expression in DC prevents FOXP3+ regulatory T cell (Treg) induction in mesenteric lymph nodes (MLN) and promotes an inflammatory intestinal CD4 response against gluten. 1.1 Breakdown of oral tolerance. Oral gavage with gluten in DQ8 mice raised under a gluten-free diet will determine the impact of transgenic IL-15 expression -inside or outside of the epithelium - on oral tolerance 1.2 Defect in FOXP3+ Treg induction. In vitro experiments will compare antigen-pulsed MLN DC from WT vs IL-15 tg mice in Treg differentiation assays of naïve T cells. In vivo experiments will use adoptive transfers of naïve T cells from OTII Foxp3-egfp reporter and OTII Rag congenic CD45.1 mice into WT or IL-15tg mice fed OVA. 1.3 Defect in tolerance induction is due to IL-15 signaling on DC. Preliminary data indicate that IL-15 induces IL-12 and TNFα secretion by MLN DC in a JNK2-dependent manner, and that recombinant IL-12 blocks FOXP3+ Treg differentiation and promotes inflammatory T cells. Thus, blockade or removal of IL-15, IL-12, TNFα and JNK2 will be performed to reverse the failure of Treg differentiation by IL-15tg DC in vitro. 1.4 Defect in tolerance induction results in an inflammatory adaptive anti-gluten immune response. Gluten-fed IL15tg DQ8 mice will be tested for proinflammatory anti-gluten CD4 T cells in the MLN and lamina propria and for IgG and IgA against gluten and TTG. Specific Aim 2: IL-15 induces NK transformation and villous atrophy This aim will test the hypothesis that dysregulated IL-15 expression in the epithelium and in the lamina propria synergize to induce (1) the NK-transformation of IE-CTL and (2) the expression of NK receptor ligands on intestinal epithelial cell (IEC) to cause IEC death and villous atrophy. 2.1 NK transformation. DQ8 mice overexpressing IL-15 in epithelium (DQ8/V-IL15tg), outside epithelium (DQ8/Dd-IL15tg), or in both (DQ8/V-IL15tg/ Dd-IL15tg) wil be examined under gluten free conditions or following oral gluten challenge to determine the impact of IL-15 overexpression at different sites on activating and inhibitory NK receptor expression as well as cytolytic granules (granzyme) by IE-CTL before and after gluten challenge. 2.2 NK ligand expression. The same mouse models as above will be examined for expression of NK ligands by IEC (Rae-1, H60, Qa1) and for epithelial cell destruction (BrdU turnover) before and after gluten challenge. 2.3 Evaluate anti-IL-15 therapy. We will use antibodies that neutralize IL-15 or block IL-15 signaling without affecting signaling through the high affinity IL-2 receptor (TM-beta1 antibody from Dr. Waldmann) to evaluate their potential for reversing the loss of oral tolerance and/or NK transformation of IE-CTL. Specific Aim 3: Human studies of IL-15, NK transformation of IE-CTL and anti-gluten CD4 T cells in relatives of celiac patients. While SA1 and SA2 aim to model in mouse our previous findings in human patients, SA3 returns to humans to test predictions derived from the mouse results. We will investigate a cohort of celiac family members with normal histology (no villous atrophy), where our preliminary studies have identified partial components of the celiac spectrum. These include IL-15 upregulation in the epithelium, NK transformation of IE-CTL, or anti-gluten adaptive immunity (assessed by presence of anti-gluten and anti- TTG antibodies). 3.1 Expression of inhibitory and activating NK receptors. We will test the hypothesis that upregulation of NKG2D is found in relatives with high levels of IL-15 expression in the epithelium, but that downregulation of inhibitory CD94/NKG2A receptor and acquisition of activating NK receptors that are not directly regulated by IL-15 (e.g. CD94/NKG2C) are observed in individuals, who in addition have anti-gluten adaptive immunity. 3.2 Longitudinal studies. This aim will test the hypothesis that emergence of vilous atrophy in individuals with anti-gluten adaptive immunity correlates with the upregulation of IL-15 in the intestinal epithelium. Collectively, these studies will not only provide new insights into the pathogenesis of celiac disease and the major impact of dysregulated IL-15 expression but also, importantly, will guide and refine new generation animal models. Because a strict lifelong gluten-free diet imposes tremendous constraints on patients, such models are long overdue to test alternative therapies that wil be developed in the near future. !